Chemokines Induce Wnt-Frizzled Gene Expression in Human

The directed movement of leukocytes towards a site of infection is central to the immune response. Chemokines have been shown to induce and direct adhesion, chemotaxis, activation, and degranulation of human and rodent leukocytes both in vitro and in vivo. Stromal cell derived factor-1 alpha (CXCL12) and macrophage inflammatory factor-3 beta (CCL19) are two important chemokines that regulate T cell motility and activation under normal and inflammatory conditions. Despite numerous reports examining the function of chemokines, little is known about the molecular changes induced by these ligands. We have identified by microarray analysis differentially expressed genes in human T cells following treatment with CXCL12 or CCL19. In primary T cells, it was observed that the genes associated with non canonical Wnt signaling pathway are significantly induced by chemokines compared to vehicle control-treated cells. The non-canonical Wnts, Wnt5a and Wnt10a, along with their receptors Frizzled2 (Fzd2) and Frizzled3 (Fzd3) were significantly induced upon CXCL12 and CCL19 treatment, respectively, in a time-dependent fashion. The up regulation of these genes was confirmed by real time PCR and western blot analysis. In addition, the transcriptional activation of both Wnt5a and Wnt10a promoter by CXCL12 and CCL19 was further confirmed by electrophoretic mobility shift assay (EMSA). siRNA knockdown of Wnt5a in primary T cells significantly inhibited CXCR4 and CCR7 signaling and function suggesting an important intermediary role for the Wnt-Fzd pathways in chemokine-chemokine receptor function. Together, these results provide insight into chemokine-induced gene activation and implicate the possible involvement of the non-canonical Wnt signaling pathway in chemokine activation and T cell trafficking. We are also currently verifying and characterizing several additional gene families that are highly expressed in T cells after migration in response to or simply stimulation with CXCL12, CCL19, gp120 and HIV-1 virus. Moreover, the role of lipid rafts in chemokine biology and HIV infectivity are also under examination using microarray analysis. A greater understanding of the transcriptional signals differentially induced by the ligation of various chemokine receptors may provide a means to dissect the pathways by which these chemoattractants induce cell migration and activation as well as any host transcriptional signals important in HIV entry and replication.